Precision Mapping of Midbrain and Striatum Networks

DESCRIPTION (provided by applicant): Functional magnetic resonance imagining (fMRI) has
revealed two major principles of the functional organization of the ventral temporal cortex (VTC) in
human adults. First, some regions of VTC respond selectively to a specific category of stimuli, such as
the fusiform face area (FFA) which responds more to faces than to any other stimulus category. The
second principle of organization is that different categories of stimuli have systematically distinct
patterns of response across the entire VTC. How do these two key aspects of VTC functional
organization in adults arise in development? The goal of my research program is to discover if these
organizing principles are present in the infant brain (Aims 1 and 2) and design computational models to
test different theories of cortical development (Aim 3). The dissertation work in this proposal will provide
invaluable data toward the goal of refining theories of cortical development. In addition to innovations
that enhance the quality of awake infant fMRI data, Aim 1 provides the first evidence that like adults,
infants have face-selective responses in the FFA, scene-selective responses in the parahippocampal
place area (PPA), and body-selective responses in the extrastriate body area (EBA). Aim 2 directly
follows this up by asking if infants have systematically distinct patterns of response across higher- level
visual areas that are similar to those found in the adult brain. The F99 phase of this proposal will
provide training to optimize machine learning (ML) techniques that can withstand the unique challenges
of infant fMRI data – specifically unbalanced and missing data. The F99 phase will be conducted at
MIT, an intellectual environment with access to leaders in the fields of ML, cognitive neuroscience, and
computational neuroscience. Finally, Aim 3 of this proposal is to build computational models designed
to test current theories of cortical development. The K00 phase of this proposal will provide training on
the design and implementation of artificial neural networks (ANNs) models as well as training on the
best methods to test ANN models using infant fMRI data. Research for the K00 phase will provide a
new mentorship experience with an established investigator in computational neuroscience and will
take place at an institution with a thriving intellectual environment that has access to an MRI scanner
and the computational resources necessary to build a variety of ANN models. In summary, the
objective of the proposed research is to determine if the principles of functional organization in the adult
brain are present in infants. Insights from this proposal will advance and refine theories of cortical
development and have the potential to be applicable to other domains such audition and language.
Further, by combining my predoctoral training in awake infant fMRI with my proposed postdoctoral
training in computational modeling, the proposed research will enable me to become an independent
investigator and leader in the field of computational developmental neuroscience.

Public health relevance
PUBLIC HEALTH RELEVANCE: The last 20 years of cognitive neuroscience has revealed the functional architecture of the human brain with an exquisite degree of detail yet has left wide-open the question of what guides the precise development, organization, and structure of the human mind. This proposal outlines a plan to unify developmental cognitive neuroscience and computational cognitive neuroscience to uncover the starting state of the human visual system and how it develops. The proposed research stands to not only inform and refine theories of cortical development and inform our understanding of neurodevelopmental differences, but also has the potential to begin to unravel one of the most intriguing questions available to humanity: what are the origins of the human mind?